Filling the Gaps: A Multi-Method Investigation of Premium Cigar Use and Marketing to Inform the Regulation of Cigar Products

PROJECT SUMMARY/ABSTRACT
Premium cigars, which were responsible for the cigar boom in the late 1990s, are now experiencing a
resurgence. Through litigation, political forces have succeeded in protecting premium cigars from regulatory
oversight via a series of court decisions. Ultimately, a court ruled to vacate FDA of its authority to regulate
premium cigars in August 2023. The lack of evidence on the public health impact of premium cigars (e.g.,
effects on initiation and use among young people) played a major role in these court decisions. Given the
paucity of evidence, the FDA commissioned the National Academies of Sciences, Engineering, and Medicine
(NASEM) to evaluate the available evidence on premium cigars and to identify future research needs. As noted
in the NASEM report, most data on cigar use has either been non-specific (i.e., does not distinguish between
cigar types) or has focused on inexpensive, mass-produced cigars. The limited data on users of premium
cigars suggest that they are distinct from users of other cigars and that their patterns of use also differ. The
negative health effects and extent of addiction of premium cigars vary based on use patterns, therefore
examining how premium cigars are used is essential for understanding their impact on public health. Research
is also needed on factors that impact patterns of use, such as exposure to cigar marketing. Tobacco marketing
is a risk factor for tobacco use in the general population—young people in particular—and marketing research
is well-established for cigarettes and other cigars. Yet, research is limited for premium cigars. Premium cigars
are not heavily promoted via traditional channels like other tobacco products (e.g., mainstream magazines),
but are the focus of lifestyle magazines (e.g., Cigar Aficionado) and online marketing (i.e., websites and social
media). Yet the content and impact of premium cigar messaging on perceptions and behavioral intentions in
both users and vulnerable non-users (e.g., young adults), remains largely unexamined. The central objective of
this multi-method study is to begin to address priority research gaps identified in the premium cigar NASEM
report, and to serve as important precursor to a R01 proposal that comprehensively examines perceptions,
patterns, severity of dependence, and influences (e.g., marketing) of premium cigar use over time. However,
the findings from this R21 can also be used immediately to inform federal, state, and local decision making
regarding premium cigars. Specifically, we aim to: 1) Understand consumer experiences and perceptions of
premium cigars via focus groups; 2) document and characterize premium cigar marketing via a longitudinal
content analysis; and 3) assess the effect of features from premium cigar advertisements on product
perceptions and intentions via an online survey experiment.

Public health relevance
PROJECT NARRATIVE The purpose of this multi-method study is to understand how premium cigars are used, how they are promoted, and to identify how premium cigar marketing efforts influence product perceptions and behaviors. The relevance of the proposed research to public health is its ability to fill important gaps in the knowledge of premium cigar use to inform federal, state, and local level policy efforts to regulate premium cigars.